2023 Modulation of Neural Circuits and Behavior Gordon Research Conference & Gordon Research Seminar

Project Summary
The 2023 GRC chairs are organizing a Gordon Research Conference (GRC) with an associated Gordon
Research Seminar (GRS) for young scientists on “Modulation of Neural Circuits and Behavior” from May 21-
26, 2023, in Les Diablerets, Switzerland. Brains adjust information processing and optimize behaviors in
response to ever-changing environmental demands. This astonishing flexibility relies on the modulation of
brain functions at multiple levels, from synapses to neural circuits, and occurs over a wide range of time
scales. The modulation of brain functions regulates basic biological states such as feeding, sleep or sex, and it
is of key importance for cognitive brain functions such as attention and learning. Deep insights into
neuromodulation are not only critical to understand the neural basis of intelligence and behavior but also to
understand how different mental states, motivation, salience, and other important phenomena are controlled.
Moreover, mechanistic insights into neuromodulatory mechanisms are key to understand brain dysfunctions
and diseases including depression, post-traumatic stress disorder, and many others. The 2023 “Modulation of
Neural Circuits and Behavior” GRC/GRS will bring together scientists with diverse backgrounds to discuss
current concepts and exciting new results in this growing field. The meeting will cut across disciplines and
model organisms and focus on topics that have a high potential to synergize. Rather than following traditional
subdivisions of the broad field of neuromodulation, the session topics will bridge between scientific
communities and disciplines. The organizing committee expects that the organized and informal discussions
will generate new insights and highlight promising directions of future progress.

Public health relevance
Project Narrative Animals constantly adjust their behavior in response to predictable and unexpected changes in their external and internal environment, and it is this neuromodulation that distinguishes brains from sophisticated robots. Neuromodulation straddles all of neuroscience and impacts all healthy and disease states. The goal of this 2023 Modulation of Neural Circuits and Behavior GRC and GRS is to bring a diverse group of scientists together to showcase their latest findings, share insights and research strategies, and establish discussion and collaboration across fields to better understand these findings.